Admin Core

Abstract
Administrative Core A will provide an infrastructure for this Program Project Grant, “New
Costimulatory Pathways: Functions and Interactions”, to enable this PPG to continue to be a
highly interactive and integrated program. Core A will serve as a centralized organizational
structure that provides administrative support to enable the Project investigators and their
personnel to focus on their experimental and scientific goals. Dr. Sharpe, Program Director of
this P01 grant, will provide leadership and direction for operations of the Administrative Core,
which will be based at Harvard Medical School. The Administrative Core will be responsible for
carrying out the following functions: a) provide the infrastructure for overall management and co-
ordination; b) facilitate and promote interactions and communication among program
investigators and administrative personnel; c) maintain a Dropbox for data sharing; d) assist the
Program Director and Principal Investigators with oversight of scientific, fiscal, regulatory and
compliance matters, and preparation and review of yearly progress and financial reports; e) plan
and coordinate External Scientific Advisory Group (ESAG) meetings; and f) facilitate sharing of
tools provided by the scientific cores with PPG participants and the scientific community. To
achieve these goals, Core A has the following Specific Aims. Aim 1: To provide
administrative support for the PPG. Core A will provide administrative support and
coordination to facilitate effective communication and interactions among all participants in the
PPG projects and cores, including scheduling of regular scientific group meetings by
teleconference and in person to enable PPG investigators to share data, plan experiments, and
enhance their collaborations. Core A also will monitor scientific progress, establish and
coordinate interactions with the ESAG, prepare and submit annual progress reports, provide
fiscal oversight, ensure institutional compliance with fiscal, regulatory and scientific issues, and
conflict resolution. Aim 2: To coordinate sharing of data and resources. Core A will host and
manage a web-based secure portal for data sharing among the three PPG projects and two
scientific cores to facilitate sharing of data in real time, planning of future experiments and
collaboration, and coordinate sharing of data and resources with the research community.
Through these specific Aims, we will create an Administrative Core structured to implement
processes/procedures to enable the success of this highly collaborative program.

Public health relevance
Narrative Core A will provide administrative support to the three Projects and two scientific Cores in this Program, facilitating interactions and communication among investigators. Core A also will oversee scientific, fiscal, regulatory and compliance matters, and coordinate the sharing of data and resources among PPG investigators, and with the scientific community.